Tackling Undruggable Cancer Targets using Chemoproteomic Platforms

One of the biggest challenges facing cancer drug discovery is that >90 % of the proteome is
currently considered “undruggable” because most proteins do not possess known binding
pockets or “ligandable hotspots” that can be pharmacologically and functionally targeted for
therapeutic benefit 1. Tackling the undruggable proteome requires the development of
innovative technologies for ligand discovery AND the discovery of novel therapeutic modalities
to functionally manipulate the undruggable proteome for therapeutic benefit. The Nomura
Research Group is focused on reimagining druggability by advancing and applying
chemoproteomic platforms to tackle the undruggable proteome, towards developing
next-generation therapies and therapeutic modalities for cancer.

Public health relevance
The Nomura Research Group is focused on reimagining druggability by advancing and applying chemoproteomic platforms to tackle the undruggable proteome, towards developing next- generation therapies and therapeutic modalities for cancer.